Stuart T. Hauser Research Training Program in Biological and Social Psychiatry

This is submission of a competitive renewal of a T32 Institutional Training grant, entitled The Stuart T. Hauser
Research Training Program in Biological and Social Psychiatry. It is ending its 42nd year of a very successful
post-doctoral program for MDs, PhDs, and MD/PhDs. Drs. Hauser and McCarley provided leadership from
its inception and Drs. Shenton, a former trainee, joined as Associate Director in 1994, and became PI in
2008. Dr. Marek Kubicki has now joined as multiple principal investigator. We plan to continue this
intentionally broad, interdisciplinary psychiatry program, which fits well with NIMH’s mission to “transform our
understanding of mental illnesses” and “to pave the way for prevention, recovery, and cure.” The rationale is
quite clear – to train the most diverse and outstanding young investigators, and to equip them with the tools
and knowledge needed to succeed in developing their own research careers in biological and/or social
psychiatry, and to understand, treat, and ultimately prevent and possibly cure mental illness. We also follow
NIMH’s mission to “foster innovative thinking” and to ensure “an array of novel scientific perspectives” that
are used “to further discovery in the evolving science of brain, behavior, and experience.” The program is
interdisciplinary and has as its cornerstone a weekly 1.5-hour seminar that includes a 3-month grants module
to demystify the grant process. Issues relevant to the ethical and reproducible conduct of research are
discussed as are the development of skills needed for a successful clinical research career. Trainees also
present their work, and invited speakers discuss their research careers. Trainees work with outstanding
preceptors in their chosen field to further develop their expertise, and to ensure the best training possible to
support individual initiated investigator research. There are 38 preceptors, across multiple research areas
and sites, who help to evaluate candidates and serve as mentors. Trainees devote two years to the program
with the goal that they leave with the skills needed to conduct their own independent research or join
established clinical research teams as junior colleagues. In the current grant cycle (4 years), trainees have
received 26 awards during their time in the T32, some examples include: an NIMH K23 Mentored Patient-
Oriented Research Career Development Award, two NIH Clinical Research Loan Repayment awards, five
Society Travel awards, three Best Poster awards at conferences, two Harvard Medical School Livingston
Awards, a Postdoctoral Excellence in Mentoring Award, a Visionary Grant Award from the American
Psychological Foundation, a McLean Hospital Presidential Award, and an Alkemes Pathways Research
Award, among others. Trainees fill out a needs assessment form when they begin and then fill in gaps in
knowledge with relevant courses. We recruit underrepresented minorities and include underrepresented
minorities among our preceptors. Program Advisory Committee, Diversity and Inclusion Committee, and
Fellows evaluate the program each year to help us improve it.

Public health relevance
8. NARRATIVE Mental illness is a major health problem; The Stuart T. Hauser Research Training Program in Biological Psychiatry and Social Psychiatry provides research and mentor-mentee opportunities, as well as core and individualized curricula, that are critical for developing the next generation of scientists in biological, developmental, and translational psychiatry. This program, ending its 42th year, will train the most diverse and talented young investigators, and equip them with the tools and knowledge needed to succeed in developing their own research so that they can better understand, treat, and ultimately prevent and possibly cure mental illness. The relevance of the program is that we need to improve the health care of those with mental illnesses and this can only be done by investing in the next generation of clinical researchers who will make mental illness more tractable via novel discoveries that lead to improved treatment.